Mayo Clinic Prospective Resource for Biomarker Validation and Early Detection of Pancreatic Cancer

Pancreatic ductal adenocarcinoma (PDAC) is typically detected at late stage due to absence of a cancer
screening strategy, with concomitant poor survival rates. Detection of PDAC at an early stage positively impacts
survival, and currently screening in eligible high-risk individuals (HRIs) defined by family history and germline
mutation status is considered best practice. The overall goal of this proposal is to use knowledge gained during
the last grant period to considerably enhance our ability to develop and validate the diagnostic performance of
new blood protein and methylated DNA (MDM) biomarkers for early detection of PDAC, using prospective
specimen collection and retrospective blinded evaluation (PRoBE) compliant methods. We hypothesize that a
combination of proteins, MDMs, and CA19-9 will accurately identify early stage PDAC in HRIs. We will assess
the performance characteristics of our approaches in early stage and pre-diagnostic phase of PDAC and identify
approaches that are optimized for clinical translation as an early detection tool using HRIs. For over two decades,
Mayo Clinic’s prospective biospecimen resources have accrued, using standardized high-quality procedures,
well-annotated biospecimens from thousands of PDAC patients including those with germline mutations in
pancreas cancer susceptibility genes, high risk members in familial pancreatic cancer kindreds, patients with
high-risk pancreatic conditions, and healthy controls. We have also launched the PCDC Signature Protocols at
our center. Among those at risk with biospecimens who we have followed longitudinally over two decades,
incident PDAC cases have developed, enabling us to utilize novel approaches to address the challenges and
better design PRoBE phase 3 studies. Based on our findings in the last grant period, we now focus on tailoring
samples for PRoBE phase 2 studies and characterizing performance to improve phase 3 studies. Our approach
will allow us to assess, for example, variability in biomarker expression for intended use HRI settings, and
temporality of biomarker expression to improve the ability to detect early onset PDAC. Our Specific Aims are to:
1) Accrue formal biospecimen sets from blood sample products and pancreatic cyst fluid suitable for PCDC
biomarker studies; 2) Leverage our past knowledge and experience to develop new biomarker panels using
tailored phase 2 designs and incorporating covariates to refine detection (age, sex, race, smoking, personal
history of diabetes mellitus, symptoms at diagnosis) to optimize detection; and 3) Evaluate needed performance
parameters that will inform the design of a successful phase 3 study for PDAC in a surveillance setting of HRIs.
Our multidisciplinary team is committed to continue its leadership and contribution to the PCDC organization to
advance the early detection of pancreatic cancer. Our project leverages existing infrastructures and biospecimen
banks of pancreatic cancer and other pancreatic diseases at Mayo Clinic and University of Pennsylvania, and it
will extend new prospective collections of blood and pancreatic cyst fluid from patients, contributing to PCDC
Signature Protocol cohorts and a PCDC central biorepository.

Public health relevance
PROJECT NARRATIVE Detection of PDAC at an early stage positively impacts survival, and screening in eligible high-risk individuals (HRIs) defined by family history and mutation status is considered best practice. The overall goal of this proposal is to use our accumulated knowledge to considerably enhance use of new blood protein and methylated DNA (MDM) biomarkers for early detection of PDAC. We will leverage our extensive biospecimen resources to test whether a combination of proteins, MDMs, and CA19-9 will accurately identify early stage PDAC in HRIs.